Brainstem as an early site in AD and FTLD: closing the etiopathogenic gap

Abstract Features shared by all neurodegenerative diseases represent critical research targets. All follow a characteristic, anatomical sequence, with lesions that spread along functional neuronal network pathways. Despite these commonalities, each disease features a distinct anatomical pattern of early regional vulnerability. These disease-specific anatomical patterns guide translational research by focusing attention on the most relevant targets in humans and model organisms and emphasize the need to identify which brain areas degenerate first in each disease. Strong evidences suggest that specific brainstem (BS) nuclei develop neurofibrillary changes before the cortex in AD. In FTLD, early reports suggest BS neurodegeneration, but few studies have addressed this issue using TDP-43. This information may prove relevant for deciphering early regional vulnerability, anatomical progression and possible non- cognitive symptomatology. Our long-term goal is to provide an integrated picture of BS vulnerability in AD and FTLD-TDP and to incorporate this understanding into the etiopathogenesis of these diseases. The overall objective of this application is to identify the BS histopathological and cytoarchitectonic changes in AD and FTLD-TDP by using a comprehensive network-based approach in well characterized human brains. We will study how often and early these nuclei are involved, whether the changes are symmetric and have a topographical gradient, and which clinical manifestations are associated. This proposal is based on the hypothesis that selected BS nuclei are interdependently and constantly involved in very early stages of AD and FTLD-TDP. Clarifying BS involvement in these diseases will facilitate development of biomarkers, improve diagnostic clinical criteria, and suggest therapeutic targets. The hypothesis will be tested by pursuing two specific aims: To determine the chronology, severity, interdependence, and symptom-relevance of neuropathological changes in the isodendritic core in AD vs. healthy elderly controls and in FTLD vs. healthy elderly controls. This approach is innovative because it utilizes brains processed into thick histological slides and 3D reconstructed. This method is superior in quality, quicker and more economical than the traditional methods and renders excellent stereological and immunohistochemical studies. In addition, the control groups will be composed of a large number of difficult-to-get healthy elderly. This proposal is significant because it is expected to that the knowledge gained will highlight unrecognized early symptoms and suggest new biomarkers and potential therapies. Integrative histopathological and cytoarchitectonic studies remain critical to understanding AD and FTLD and will serve as a foundation for ongoing and future translational research.

Public health relevance
Project narrative The proposed research is relevant to public heath because the high economic and social costs associated with neurodegenerative dementias may soon become an unbearable burden to society and effective disease- modifying treatments remain elusive. For this reason, closing important gaps in the understanding of dementia etiopathogenesis as proposed in this proposal by clarifying the involvement of BS nuclei in AD and FTLD-TDP and proposing novel targets for prevention and treatment of these devastating diseases are relevant to the NIH's mission of reducing burdens of illness and disability. __SpecificAimsTextDelimiter__ The high economic and social costs associated with neurodegenerative dementias may soon become an unbearable burden to society. This threat has led to an invigorated research effort, resulting in significant progress in the understanding of the neurobiology of prevalent disorders, such as Alzheimer's disease (AD) and frontotemporal lobar degeneration (FTLD). However, effective disease-modifying treatments remain elusive. Features shared by most neurodegenerative diseases represent critical research targets. All follow a characteristic, non-random anatomical sequence, with lesions that spread along functional neuronal network pathways (Rabinovici et al., 2007). Furthermore, diagnosis-defining symptoms manifest only after a prodromal phase that may last decades (Amieva et al.,2008). Despite these commonalities, each disease features a distinct anatomical pattern of early regional vulnerability. These considerations emphasize the need to identify which brain areas degenerate first in each disease. Human neuropathological studies have proven essential in advancing knowledge about incipient neurodegenerative diseases. These approaches have demonstrated the progression of tau changes in AD (Braak & Braak, 1991) and have transformed our understanding of early PD by illustrating that the brain changes begin in the dorsal motor nucleus of the vagus and ascend through several symptom-relevant brainstem nuclei before reaching the substantia nigra (Braak et al,2003.). These disease-specific anatomical patterns guided translational research by focusing attention on the most relevant targets in humans and model organisms. For diseases other than PD, previous efforts have failed to correlate observed changes with non-cognitive symptoms or construct a clear spatiotemporal pattern. In 2009, an ample anatomical analysis demonstrated that the midbrain dorsal raphe nucleus (DRN) develops neurofibrillary changes even before the entorhinal cortex, the first affected cortical area in AD (Grinberg et al.,2009). The DRN is a central component of the isodendritic core, an interconnected network which modulates basic physiologic processes, that also show early AD pathology. In FTLD, early reports suggest brainstem neurodegeneration (Jakob, 1979), but few studies have addressed this issue using TDP-43, which is the primary disease protein in over one half of FTLD patients. Our preliminary data suggest that specific brainstem networks show consistent TDP-43 inclusions, and that this involvement follows a predictable pathway. Since brainstem nuclei are interconnected with supratentorial structures, it is important to place it within an etiopathogenic context in AD and FTLD-TDP. This information will complement knowledge accumulated on supratentorial injury and may prove relevant for deciphering early regional vulnerability, anatomical progression and possible non-cognitive symptomatology. Our long-term goal is to provide an integrated picture of brainstem vulnerability in AD and FTLD-TDP and to incorporate this understanding into their etiopathogenesis. The overall objective of this application is to identify the brainstem histopathological and cytoarchitectonic changes in AD and FTLD-TDP by using a comprehensive network-based approach. We will study how often and early these nuclei are involved, whether the changes are symmetric and have a topographical preference, and which clinical manifestations are associated. Our central hypothesis, based on preliminary data and previous work, is that selected brainstem nuclei are interdependently and consistently involved in very early stages of AD and FTLD-TDP. The rationale for the proposed research is that clarifying brainstem involvement in these diseases may facilitate development of innovative biomarkers, improve diagnostic clinical criteria, and suggest novel therapeutic targets. We plan to test our central hypothesis by pursuing the following two specific aims: 1. To determine the chronology, severity, interdependence, and symptom-relevance of neuropathological changes in the isodendritic core in AD vs. healthy elderly controls. Hypothesis 1a: Anatomical changes will follow a stereotyped pattern of involvement. Hypothesis 1b: The DRN will be the site of first injury. Hypothesis 1c: Anatomical changes within individual nuclei will correlate with specific clinical symptoms. Hypothesis 1d: Neurofibrillary changes precede neuronal loss. 2. To determine the chronology, severity, interdependence, and symptom-relevance of brainstem neuropathological changes in FTLD vs. healthy elderly controls. Hypothesis 2a: Anatomical changes will follow a stereotyped pattern of regional involvement in which the earliest vulnerable nuclei are common to all FTLD-TDP subtypes. Hypothesis 2b: Observed changes within individual nuclei will correlate with specific clinical symptoms. Hypothesis 2c: TDP-43 inclusions precede neuronal loss. Hypothesis 2d: FTLD-TDP related brainstem vulnerability is different from AD vulnerability The proposed work is expected to clarify the involvement of brainstem nuclei in AD and FTLD-TDP. The knowledge gained could highlight unrecognized early symptoms and suggest new biomarkers and potential therapies. Integrative histopathological and cytoarchitectonic studies remain critical to understanding AD and FTLD and will serve as a foundation for ongoing and future translational research.